CURE ID App for Infectious Disease Case Reporting

NIH and the U.S. Food and Drug Administration announced the global launch of CURE ID on December 5, 2019. The repository is a collaboration between the FDA and the National Center for Advancing Translational Sciences (NCATS), which is part of the National Institutes of Health (NIH).

The repository captures clinical outcomes when drugs are used for new indications, in new populations, in new doses or in new combinations. Health care professionals generally may choose to prescribe or use a legally marketed human drug or medical device for an unapproved or uncleared use when they judge that the unapproved use is medically appropriate for an individual patient. The systematic collection of real-world experience in the app will help identify drug candidates for additional study, encourage further drug development, and may serve as a resource for practitioners making individual patient treatment decisions in the absence of established safe and effective options. Repurposing approved drugs for new clinical indications can potentially offer an efficient drug-development pathway for treatments of diseases and conditions that have few or no therapeutic options.

In the context of the COVID-19 global pandemic, FDA announced the launch of a new Partnership to use the CURE ID platform to capture real-world data to identify potential treatments for further study. The National Center for Advancing Translational Sciences (NCATS) is partnering with FDA and the Critical Path Institute (C-Path) on the CURE Drug Repurposing Collaboratory (CDRC). CDRC will provide a forum for the exchange of clinical practice data to inform potential new uses of existing drugs for areas of high unmet medical need, advancing research in these areas. CDRC will focus on capturing relevant real-world clinical outcome data through the FDA-NCATS CURE ID platform. In a pilot project focused on COVID-19, CDRC will use data collected via the CURE ID platform to aggregate global clinician treatment experiences to identify existing drugs that demonstrate possible treatment approaches that should be studied further. Presently, CURE-ID has undergone a ground up rewrite to keep up with current mobile and web technologies. The case report form has been simplified to allow greater customization options in order to quickly react to new outbreaks and epidemics. The user experience was also improved based on input from user research.